A Compensatory Muscle-to-Neuron Feedback Pathway in C. Elegans

Project Summary/Abstract
Pathological disturbances caused by neuromuscular disorders can disrupt the motor circuits that drive
muscle stimulation. For example, muscle paralysis induces compensatory changes in motor circuit excitability.
Although much is known about neuronal mechanisms that alter intrinsic excitability, far less is known about the
intercellular mechanisms that monitor and control synaptic strength at the circuit level, perhaps because the
complexity of mammalian circuits has precluded intensive efforts to characterize circuit-level coordination of
network excitability. This proposal harnesses the simple genetics and known neuroanatomy of C. elegans to
investigate a novel inter-tissue feedback pathway that couples neuromuscular junction (NMJ) or muscle activity
with synaptic strength of synapses on interneurons that reside two synaptic layers upstream of the NMJ.
This feedback pathway was discovered while characterizing the Vascular Endothelial Growth Factor
Receptors ver-1 and ver-4, and their ligand pvf-1, which are hits from an RNAi screen for genes that affect a
mechanosensory reflex circuit. When excitatory signaling at the NMJ is lost or when muscles cannot contract,
a sensor generates a signal to the command interneuron to increase its synaptic strength to compensate for
decreased behavioral output (reflex response). Literature from the muscle hypertrophy field points to a sensor
candidate, unc-22/titin, which has spring-like properties and a stretch-activated kinase domain. It is well
established that titin kinase initiates hypertrophy signaling, an active response to muscle overload that includes
muscle growth and sarcomere reorganization. Does titin initiate a feedback signal that adjusts network strength
to control drive onto the muscle? This proposal tests the hypothesis that a sensor in muscle, perhaps
unc-22/titin, detects changes in muscle contraction and initiates an inter-tissue signal, mediated by
pvf-1 and ver signaling, that modulates the synaptic strength of a command interneuron two synaptic
layers upstream from muscle. Preliminary results supporting this hypothesis show that animals with
defective NMJ signaling or muscle contraction have increased surface glutamate receptor (GluR) levels
(correlate of increased synaptic strength) in interneurons that drive the NMJ. Loss of either unc-22/titin or pvf-1
block this increased GluR abundance, implicating both in the feedback pathway. Proposed experiments will
characterize feedback pathway triggers, test if unc-22/titin is a muscle stretch sensor that initiates the feedback
signal, and identify the inter-tissue signal by examining the role of pvf-1 and ver signaling in this pathway.
Completion of this exciting project will result in a novel description of a mechanism that neuronal
circuits use to monitor circuit output and adjust synaptic strength accordingly. Further, this project identifies a
retrograde signal that operates more than one synaptic layer upstream in a circuit, a novel demonstration of
compensatory plasticity that may guide similar investigations of circuit-level retrograde signaling in mammals
and spur new ideas for treating neuromuscular disorders.

Public health relevance
Project Narrative Although appropriately tuned motor circuit strength is paramount to achieve coordinated movement, the complexity of mammalian neuronal circuits has precluded intensive efforts to characterize circuit-level coordination of synaptic strength. Experiments outlined in this proposal investigate a novel compensatory feedback pathway that couples muscle contraction with neurotransmitter receptor levels in neurons several synaptic layers upstream in a circuit that controls movement in C. elegans. Results will provide a novel description of a mechanism that neuronal circuits use to monitor circuit output and adjust synaptic strength accordingly, which may be a novel therapeutic avenue for certain neuromuscular disorders.